Transforming HIV vaccine design with a hybrid technology that leverages features of mRNA and protein nanoparticle platforms

Proposal Summary/Abstract
The HIV-1/AIDS epidemic continues to affect ~40 million people globally, yet there is still no effective vaccine
largely due to HIV-1’s enormous genetic diversity. The primary goal for HIV-1 vaccine efforts is to elicit broadly
neutralizing antibodies (bNAbs) that neutralize a wide range of HIV-1 strains by targeting conserved epitopes on
the HIV-1 envelope (Env) surface protein. However, eliciting bNAbs through vaccination is challenging as
inferred germline B cell receptor precursors of most bNAbs do not bind Env and are present at low frequencies.
Moreover, bNAbs exhibit unusual features, including high levels of somatic hypermutation. Germline-targeting
(GT) vaccination strategies aim to elicit bNAbs through sequential immunization. GT immunogens have been
engineered to bind bNAb precursor B cells to initiate the response. Subsequent sequential boosting with
increasingly native-like Env immunogens is intended to promote sustained affinity maturation and drive bNAb
development. However, regular mRNA and protein nanoparticle (NP) approaches to deliver GT prime and boost
immunogens have produced only weak heterologous NAb responses in animal models. Thus, innovative vaccine
strategies that promote bNAb evolution are urgently needed. We recently developed a hybrid mRNA vaccine
technology that leverages features of both mRNA and protein NP vaccines through genetic encoding of self-
assembling enveloped virus-like particles (eVLPs). eVLP assembly is achieved by inserting an ESCRT-recruiting
domain (ERD) into the cytoplasmic tail of viral surface proteins, which recruits proteins from the Endosomal
Sorting Complex Required for Transport (ESCRT) pathway. SARS-CoV-2 immunizations in mice have shown
that a 1st generation hybrid mRNA vaccine elicited superior NAb potency, breadth, and durability compared to
regular mRNA and protein NP vaccines, in concert with potent T cell responses. To further increase the
effectiveness of hybrid mRNA vaccines, we have designed optimized ERDs that substantially increase eVLP
production compared to the 1st generation design. Building on the promise of this technology to elicit Ab
responses with enhanced potency and breadth, we propose to evaluate hybrid mRNA vaccines as a platform for
GT vaccination in preclinical models. Our proposed research seeks to accomplish the following goals: i) Using a
model GT immunogen, design and evaluate optimized ERDs for enhanced immunogenicity in wild-type mice to
downselect candidates for studies in humanized mice; ii) Evaluate the ability of optimized hybrid mRNA vaccines
encoding GT prime and boost immunogens to activate and mature bNAb precursors in a stringent humanized
mouse model with low bNAb precursor frequency; iii) Investigate if sequential hybrid mRNA immunizations
delivering GT prime and boost immunogens elicit heterologous NAb and potent cellular responses in non-human
primates and protect against viral challenges. We expect that hybrid mRNA vaccines will promote bNAb evolution
and induce robust T cell responses more effectively than existing vaccine approaches in preclinical models.
Thus, the hybrid mRNA vaccine platform could have a transformative impact on HIV-1 vaccine development.

Public health relevance
Project Narrative The proposed research aims to develop an innovative HIV-1 vaccine platform that could substantially impact public health by providing a robust solution to the long-standing challenge of creating an effective HIV-1 vaccine. By combining the strengths of mRNA and protein nanoparticle vaccine approaches, this hybrid technology has the potential to elicit potent, broad, and durable immune responses through the generation of broadly neutralizing antibodies and potent T cell activation. If successful, this platform could pave the way for the development of an effective HIV-1 vaccine, ultimately reducing the global burden of HIV/AIDS and improving the quality of life for millions of individuals affected by the virus.